Metastatic tracking of cancer subclones for collateral lethality prediction

PROJECT SUMMARY/ABSTRACT
Late-stage metastatic breast cancer remains a leading cause of cancer-related deaths, largely due to genomic
instability driving tumor evolution and therapeutic resistance. While DNA structural variations (SVs) are known
to be crucial in this process, existing tools for tracking these changes across tumor subclones and linking them
to functional effects are inadequate. Our group recently showed that these genomic alterations, especially
deletions, may be ideal landmarks for tracking tumor phylogeny and can be leveraged for treatment target
identification. By leveraging the unique combination of genomic data from the AURORA US Metastasis Project
and the University of Pittsburgh's Hope for OTHERS - Rapid Autopsy Program (HfO), this study proposes an
innovative integration of machine learning techniques with a comprehensive autopsy program to identify
diverse and recurrent patterns of gene deletions in metastatic disease.
Central to this project is the hypothesis that genomic deletions accumulate over the process of unstable
genomic evolution and that these identifiable patterns of genomic variation can be targeted through advanced
computational analysis. Our approach utilizes Transformer models and cutting-edge phylogeny tools to
analyze multi-omic data, creating a detailed landscape of the genomic evolution in metastatic breast cancer.
This proposal addresses the challenges of limited dataset size and complexity in machine learning applications
by directly collating said data from clinic to hospice and collecting the tissue required to capture the complete
clinical and biological context of metastatic breast cancer. It additionally leverages the unique possibility of
growing organoids from those same tissue samples for orthogonal wet lab validation of computational findings.
The project seeks to answer critical questions: 1) Are genomic deletions truncal clonal features in cancer
genomes that are persistent over time? 2) What potential therapeutic targets are hidden within the genomic
patterns of gene deletions as cancer genomes lose fundamental redundancy pathways? This project advances
the translational implementation of machine learning in elucidating complex genetic patterns in cancer
evolution to improve the precision treatment of late-stage metastatic breast cancer.
This interdisciplinary study lies at the crossroads of machine learning, cancer biology, and clinical research and
represents a unique collaboration between the University of Pittsburgh and Carnegie Mellon University. It
promises to make significant contributions to the fields of oncology, genomics, and computational biology,
ultimately improving clinical outcomes for patients with metastatic breast cancer. A fundamental issue in this
area of research is defining the best methods to process vast biological data forms into machine-readable
structures and interpretable findings; this proposal will provide essential training in developing and utilizing
those methods to support the advancement of such machine tools in the clinic and the laboratory.

Public health relevance
PROJECT NARRATIVE Metastatic breast cancer remains a leading cause of cancer deaths because, over time, tumors become increasingly complex, heterogeneous, and resistant to treatment. This research will develop new computational tools to track how tumors evolve and spread while identifying specific vulnerabilities that can be targeted with existing drugs. The proposed study will utilize molecular techniques, tissue banks, organoid models, and machine learning methods (including phylogeny algorithms and transformer models) to examine the informational landscape of metastatic breast cancer that could ultimately lead to improved treatment regimens and more precise treatment options.